Understanding how Powered Componentry Impacts K2-Level Transfemoral Amputee Gait

Project Summary
Powered prosthetic knee and ankle joints can actively generate torque, potentially enabling safe and efficient
performance of more demanding mobility tasks, such as ascending ramps and stairs or performing sit-to-stand
transitions, and improving energy efficiency. However, available powered components have been almost
exclusively developed for and tested by individuals ambulating at Medicare Functional Classification Level
(MFCL) K3-or K4. Individuals designated as K2-level ambulators (i.e., have a more limited ambulation
capacity) are typically prescribed a passive prosthesis, but these individuals have been shown to benefit from
more advanced microprocessor-controlled knees and may gain additional benefit from powered components.
Because available powered components are heavy, we developed lightweight, fully powered knee and ankle
components that can be used separately or together and are appropriate for K2-level ambulators. These
devices will allow us to evaluate the benefits associated with providing power at the knee, ankle, or knee and
ankle, and the tradeoffs associated with the additional weight and control complexity of one or more powered
components. Our goal is to determine how powered prosthetic components effect function—in terms of
metabolic cost, gait biomechanics, and functional mobility in K2-level ambulators with a unilateral transfemoral
amputation, who use a prescribed passive prosthesis. We will recruit 20 individuals, who will participate in
three aims, with the expectation that 15 will complete the study. For Aim 1, subjects will be fit first with a fully
passive device (Ottobock C-Leg 4 MPK and a Triton 1C60 Foot) and then to our fully powered device (knee-+
ankle prosthesis). They will be trained to use each device before completing the Amputee Mobility Predictor
with Prosthesis (AMPPRO) (primary outcome) as well as metabolic and biomechanical assessments, a set of
standard outcome measures, and self-report surveys (secondary outcomes). For Aim 2, we will evaluate
combinations of powered knee + passive ankle and passive knee + powered ankle, in random order. Subjects
will be trained to use each device, and the same primary and secondary outcome measures will be performed
to assess functional benefits and the effects of additional weight at the knee or ankle. In Aim 3, we will provide
intensive training to enable subjects to independently perform typical activities of daily living and achieve
personal mobility goals using the powered knee + ankle device, to determine what level of improvement K2-
level ambulators can attain. Subjects will again complete the same primary and secondary outcome measures
using the powered device and will repeat these measures using the passive device from Aim 1, to
accommodate carryover of training effects from previous Aims. The anticipated outcome is an understanding of
how power and the weight of prosthetic components affect function in K2-level ambulators, which will enable
optimal selection of components to improve functional mobility in individuals who are designated as limited
community ambulators and currently restricted to passive devices.

Public health relevance
PROJECT NARRATIVE Powered devices can more fully replace function lost due to leg amputation, but current devices are heavy and have not been studied for people designated as K2-level ambulators, who are typically prescribed passive devices but may benefit from powered devices. Our proposed project will evaluate the benefits of providing power either at the knee, ankle, or both knee and ankle, using our novel, lightweight powered knee and ankle components that are likely more suitable for K2-level ambulators. Our results will provide metabolic, biomechanical, and functional evidence to support prescription of powered components to K2-level ambulators, which may improve their independence, mobility, and quality of life, and allow clinicians to select appropriate components to optimize function, based on the individual user’s needs and preferences.